IMMUNOREGULATION AND IMMUNE RECOGNITION IN FILARIASIS AND NON-FILARIAL DISEASES

The purpose of this project is to delineate the mechanisms involved in regulating immune responses in filarial and nonfilarial disease states. Immunoregulatory studies have examined the phenomenon of antigen-specific anergy in microfilaremic patients by showing this anergy to be a result of the production of the antiproliferative cytokine, IL-10. Filter immunoplaque assays for the major cytokines have been developed and used to demonstrate that in helminth infections of humans there is an expansion of Th2 CD4+ cells. The phenotypic characterization of these Th2 CD4+ cells has shown them to be CD45RO+ HLA-DR+ CD27-; a novel method for intracellular staining for cytokines has been used to assess further the frequency of these cells. Similarly, new ways of assessing eosinophil activation have also been developed.